PHASE I TRIAL OF PACLITAXEL/GALLIUM NITRATE/FILGRASTIM (G-CSF) W/MALIGNANCY

Phase I trial of Paclitaxel as a 24 hour continuous IV infusion + Gallium Nitrate + Filgrastim (G-CSF) in patients with selected Refractory Malignancies.